Endogenous synthesis of TRAIL by glioma cancer stem cells and resistance to TRAIL therapy

PROJECT SUMMARY/ABSTRACT
Our preliminary data indicate that human glioma cancer stem-like cells (CSLCs) synthesize and secrete
tumor necrosis related-apoptosis inducing ligand (TRAIL). Consistent with this, other investigators have
demonstrated endogenous-TRAIL expression in glioblastoma (GBM) biopsies. Despite the synthesis of
endogenous-TRAIL the CSLCs continue to proliferate, suggesting endogenous-TRAIL is signaling a pro-tumor
function(s). We found that downregulation of endogenous-TRAIL inhibited proliferation in CSLCs, suggesting
TRAIL may signal for proliferation. This is supported by reports in the literature that TRAIL can signal for
proliferation, migration and inflammation in cancer cells. One potential mechanism for the failure of TRAIL in
clinical trials is that TRAIL-DRs are sequestered intracellularly effectively reducing TRAIL-apoptotic signaling
initiated at the cell surface. In non-brain cancer cells, clathrin-mediated endocytosis (CME) of TRAIL-DR
inhibits TRAIL-induced apoptosis. CME of TRAIL-DR is induced by activated dynamin-1, a large GTPase that
promotes membrane scission. In non-brain cancer cells, dynamin-1 was recently shown to be activated by
dephosphorylation by calcineurin - a protein phosphatase. In an effort to inhibit dynamin-1 activation in GBM
and block the CME of TRAIL-DR, and the resultant inhibition of apoptosis, we searched for a natural
compound that inhibits dynamin-1 or the upstream activator-calcineurin, and found that quercetin (a natural
flavonoid) directly inhibits calcineurin. Consistent with quercetin inhibition of calcineurin and thereby inhibition
of dynamin-1, our preliminary data show that quercetin and an inhibitor of dynamin-1, sensitize glioma CSLCs
to TRAIL-apoptosis. We hypothesize that: (1) an un-explored mechanism for the resistance of GBM
tumors to TRAIL is the synthesis/expression of endogenous-TRAIL that promotes pro-tumorigenic
functions in CSLCs; and (2) increased dynamin-1 protein in GBM results in increased levels of
activated dynamin-1 promoting CME of TRAIL-DR that inhibits TRAIL-apoptosis, and that quercetin
inhibition of calcineurin (calcineurin activates dynamin-1) will sensitize CSLCs to TRAIL-apoptosis. Aim
1) will determine whether knock-out (KO) or downregulation of endogenous-TRAIL in CSLCs and mouse
glioma cells alters cell proliferation, migration, chemokine/cytokine secretion or sensitivity to TRAIL-induced
apoptosis, and will dissect the necessary signaling pathway(s) for the pro-tumorigenic effect of endogenous-
TRAIL. This will be followed by studies of TRAIL-KD CSLCs/mouse glioma cells in the athymic nude or
C57BL/6 mouse brain to confirm the pro-tumorigenic effect(s) of endogenous-TRAIL found in vitro. Aim 2) will
determine whether the flavonoid quercetin decreases activation of dynamin-1 in human glioma CSLCs through
inhibition of calcineurin, thereby decreasing CME of TRAIL-DR and increasing TRAIL- apoptosis in CSLCs
propagated in vitro, and when propagated in vivo in the athymic nude mouse brain.

Public health relevance
PROJECT NARRATIVE This project will determine whether endogenous-TRAIL expressed by glioma cancer stem-like cells (CSLCs) promotes a pro-tumorigenic function in glioblastoma tumors, and the signaling pathway that is necessary for this function. The findings generated from in vitro studies in CSLCs with knock-out (KO) or knock-down (KD) of TRAIL or overexpressing TRAIL will then be tested in vivo utilizing several different orthotopic mouse models of malignant glioma, and a gene signature specific for CSLCs with TRAIL-KO/KD generated. Secondly, the project will determine whether quercetin inhibition of calcineurin causes decreased dynamin-1 activity, resulting in a sensitization of CSLCs to the pro-apoptotic effect of TRAIL; this will be tested in vitro and in vivo using orthotopic xenograft mouse models of glioblastoma.